Behavioral and neural mechanisms of chemosensation in skin-penetrating parasitic nematodes

PROJECT SUMMARY
The goal of this project is to elucidate the behavioral and neural mechanisms that mediate host seeking
and host invasion in skin-penetrating, human-parasitic nematodes. Nearly one billion individuals globally are
infected with skin-penetrating nematodes, particularly in socioeconomically disadvantaged communities with
limited waste management and healthcare infrastructure. Strongyloides stercoralis, the human threadworm, is
estimated to infect over 600 million individuals globally, resulting in chronic gastrointestinal infections, respiratory
distress, growth delays in children, and fatality in immunosuppressed individuals. Infections are expected to rise
with climate change and resistance to available anthelmintic drugs is a growing concern; therefore, elucidating
the mechanisms that mediate parasite host seeking and host invasion is crucial for developing novel strategies
to prevent and treat individuals infected with S. stercoralis and other parasitic nematodes.
Skin-penetrating nematodes freely navigate the environment as developmentally arrested infective third-
stage larvae (iL3s) and rely upon sensory cues to seek out and infect new hosts. Previous studies have shown
that the iL3s of S. stercoralis and other skin-penetrating nematode species are robustly attracted to host-
associated odorants. However, how olfactory cues drive host-seeking and host-invasion behaviors remains
poorly understood, and the neural mechanisms that mediate odor-evoked behaviors have not been investigated.
This proposal hypothesizes that skin-penetrating nematodes have evolved unique neural and behavioral
responses to olfactory cues that facilitate specific host-seeking and host-invasion behaviors. To test this
hypothesis, I will investigate the odor-evoked responses of skin-penetrating nematodes at the behavioral and
neural levels. I will use S. stercoralis for these experiments because it is a human parasite with direct health
relevance and because several genetic manipulation tools have been successfully developed for this species.
Experiments proposed in Aim 1 will characterize and quantitatively analyze motility, host-seeking, and host-
invasion responses to host-associated and non-host-associated odorants in vitro and ex vivo. Experiment
outlined in Aim 2 will identify putative olfactory neurons and utilize in vivo calcium imaging and chemogenetic
silencing to functionally characterize parasite-specific olfactory neuron response properties. Collectively, my
results will illuminate how skin-penetrating nematodes respond to host-associated odorants and how these
responses enable the parasites to specifically target human hosts. This work will provide fundamental insights
into the poorly understood field of endoparasite chemosensation and may contribute to the development of novel
preventative and treatment methods to control nematode infections.

Public health relevance
PROJECT NARRATIVE Skin-penetrating parasitic nematodes cause significant global health burdens that disproportionately impact socioeconomically disadvantaged communities. This proposal aims to identify and characterize the behavioral and neural mechanisms mediating odor-evoked host seeking and host invasion in the human-parasitic, skin- penetrating nematode Strongyloides stercoralis. Findings from this work will generate fundamental insight into parasitic nematode chemosensory biology that will inform future preventative and control methods.